University of Michigan Skin Biology and Diseases Resource-based Center

PROJECT SUMMARY - OVERALL
The overall goal of the University of Michigan Skin Biology and Diseases Resource-based Center (UM-
SBDRC) is to leverage our strengths in genomic editing, bioinformatics and mouse modelling to enable rapid
transition from discovery to function, address biological and disease context, and facilitate development of
appropriate state-of-the-art in silico approaches and in vivo mouse models of disease. A major emphasis of
the UM-SBDRC is to apply years of cutting-edge mouse modeling expertise to the study of inflammatory skin
disease using new knowledge gained through big-data approaches. Thus, the UM-SBDRC will both facilitate
and accelerate ongoing research towards new discoveries and ultimately benefit a wide range of patients with
cutaneous disorders. Two Resource Cores will be established within the UM-SBDRC: they will enhance
efficiency and translational impact of cutaneous research; provide access to unique resources and expertise;
facilitate new discoveries; and provide training and guidance regarding experimental design and analysis. In
addition, the Resource Cores will continuously innovate to maintain our research at the forefront of the field.
The Functional Analytics Core will provide unique and innovative, state-of-the art services for CRISPR/Cas9
mutagenesis in keratinocytes, with transcriptomic and epigenomic profiling of genetically-altered keratinocytes,
and integration into a systems biology pipeline for data analysis and interpretation. This core will also provide
UM-SBDRC members direct access to our bioinformatics resources and to large-scale genomic and
transcriptomic datasets of human skin disease through a searchable web-based interface. The Animal
Modeling Core will provide services for the design, development, validation, and characterization of
genetically-engineered mouse models (GEMMs) to aid in the functional validation of results generated in the
Functional Analytics Core. The Animal Modeling Core will also provide resources and guidance for GEMM
phenotyping and in vivo manipulation, including transgene induction protocols, UV irradiation, inflammation and
fibrosis models, and for establishment of cell cultures from GEMMs. The Administrative Core will provide
leadership, oversight and structure for the UM-SBDRC and build and administer a robust Enrichment
Program, which includes a Mentoring Program, Pilot & Feasibility Program, Travel Awards, Visiting Speaker
Series, and an Annual Symposium, with strong institutional and departmental support for the Center. In
summary, UM-SBDRC will provide sophisticated infrastructure and state-of-the-art resources, expertise, and
training opportunities at Michigan. This new Center is in line with the NIAMS mission to provide critical
research infrastructure, pooled facilities, services and resources to groups of investigators conducting research
on skin biology and diseases. The UM-SBDRC will enrich and enhance effectiveness of ongoing basic and
translational research, help bring outside investigators into the field of cutaneous biology, broaden the scope of
skin research, and accelerate new discoveries to ultimately benefit patients with a wide range of skin diseases.

Public health relevance
PROJECT NARRATIVE With the shift in biomedical research towards big-data and data-driven strategies, a major challenge is to robustly translate the vast amount of information generated to meaningful biological insights and clinically relevant information. The overall goal of the University of Michigan SBDRC is to leverage our strengths in genomic editing, bioinformatics and mouse modelling to enable rapid transition from discovery to function and to address biologic and disease context, as well as facilitating the development of appropriate state-of-the-art in silico and in vivo disease models. The key objective for UM-SBDRC is to accelerate ongoing skin research towards new discoveries and ultimately benefit a wide range of patients with cutaneous disorders.